Precision Medicine Initiative Cohort Program Biobank

PROJECT SUMMARY / ABSTRACT OF THE FUNDED PARENT AWARD
In his State of the Union address on January 20, 2015, President Obama announced his intention to launch the
Precision Medicine Initiative (PMI). The goal of the PMI Cohort Program is to enroll one million volunteers into
a national cohort that broadly reflects the diversity of the U.S. population and accelerate progress toward a
new era of precision medicine on a larger scale than previously possible. The objective of this proposal is to
utilize the full resources available through the Mayo Clinic Biorepositories Program and Mayo Medical
Laboratories to efficiently and cost effectively support the activities of the PMI Cohort Program with respect to
the Biobank, namely, biospecimen collection, kit assembly, biospecimen accessioning, tracking, processing,
quality assurance, storage, and distribution. Mayo Medical Laboratories, the third largest reference laboratory
in the United States, will enable efficient specimen transportation, routing, and information management
between PMI collection sites and the Mayo Clinic Biobank. The aims of this proposal are to: (1) To provide
collection kits and leverage existing sample shipment logistics to ensure specimens arrive at Mayo Clinic
Rochester in the most expedient, efficient, and safe manner possible, in accordance with all federal and state
regulations; (2) Scale up existing state-of-the-art laboratory automation and robotics to process, label, and
store biospecimens, using established protocols compliant with laboratory best practices for all steps of
specimen handling; (3) Use our high-quality, robust, and secure research laboratory information management
system (RLIMS) for detailed tracking of sample receipt, processing, storage, retrieval, and distribution, while
protecting participant confidentiality; (4) Apply our comprehensive Quality Management Program to ensure all
work carried out is of the highest quality, and safeguard the collection with robust back-up systems and plans
for disaster recovery; and (5) Work closely with the Coordinating Center, Collection Sites, and all other PMI
Cohort Program Steering Committee Members to share biobanking expertise, infrastructure, and data to
further the goals of the PMI. Overall, the Mayo Clinic Biorepositories Program laboratories combined with Mayo
Medical Laboratories provide an unparalleled ability to collect, accession, process, distribute, store, and
manage virtually any type of biospecimen on behalf of the Precision Medicine Initiative Cohort Program.

Public health relevance
PROJECT NARRATIVE The goal of the Nutrition for Precision Health (NPH) study is to develop algorithms that predict individual responses to food and dietary patterns. The biobanking infrastructure established at the Mayo Clinic for the All of Us Research Program will be used to support the biobanking requirements of the NPH study. The Mayo Clinic Biobank will provide a state-of-the-art facility and cost-effective services to ensure the success of this study.